ACHIEVING INTEGRATION ACROSS COMMUNITY SERVICES BOARDS

The Virginia Department of Mental Health, Mental Retardation and Substance Abuse Services proposes to enhance the data collection systems of the State's 40 community services boards. The goals of the project include implementation of the MHSIP recommended data sets and standards, improvement in the quality and reliability of data, and increased use of data and integration of data between community programs and inpatient facilities. The project will employ two full-time staff persons working with a Steering Committee of Community Services Board representatives. Activities will include modifying existing CSB data systems to meet MHSIP standards, developing a human resources data base, developing data audit guidelines and disseminating data analyses and reports.